OPEN LABEL SINGLE CENTER COMPARISON OF NEORAL AND GENERIC

To compare the bioavailability of Neoral liquid to a generic cyclosporine liquid The patient will receive Neoral for a week, then have a pharmacokinetic assessment. The patient converts to the same milligram dose of generic cyclosporine for one week, then have a pharmacokinetic assessment. At this time the patient will resume their initial Neoral liquid dose, and after one week, a final pharmacokinetic assessment.